RCT of a parent-focused intervention to reduce HIV risk in adolescent MSM

Project Summary
Adolescent men who have sex with men (AMSM) accounted for 79% of new HIV infections among youth ages
13-19 in the United States (US) in 2018. Less than a quarter of AMSM have ever taken an HIV test. Despite
these stark disparities in HIV incidence and testing, interventions to reduce sexual risk and increase HIV
testing among AMSM remain extremely limited. Notably, the very few intervention approaches that are
currently being explored for AMSM exclude parents. The omission of parent-focused approaches represents a
glaring gap in national efforts to end the HIV epidemic given parents’ well-documented ability to shape
adolescent sexual health, including for AMSM. Consistent with NIH priorities (PA-20-144) the goal of the
proposed research is to test the efficacy of a parent-focused intervention designed to reduce HIV risk and
increase HIV testing among AMSM. Parents and Adolescents Talking about Healthy Sexuality (PATHS) is an
online intervention we created for parents of AMSM that works to increase parent communication about sexuality
and HIV, as well as other parent behaviors supportive of sexual risk reduction. Our NIH-funded pilot RCT with a
national sample of 61 racially/ethnically diverse parent-AMSM dyads revealed that PATHS increased both
parent and child reports of multiple parent behaviors supportive of sexual health. Building on the promising
effects PATHS had on parent behaviors, the goal of the proposed study is to test whether PATHS improves
sexual health outcomes in AMSM ages 14-19. We will conduct an RCT of PATHS with 350 parent-AMSM
dyads recruited online (50% racial/ethnic minority). Parents will be randomized to receive either PATHS or an
active control, and then assessed every 3 months over a 1-year period. Primary outcomes will be evaluated at
6 months post-intervention, and then the control arm will crossover and receive PATHS, and dyads will be
followed for another 6 months. This allows us to further test the effects of PATHS in the control arm while
simultaneously modeling the longer 9- and 12-month effects in the original intervention arm. The primary (P)
specific aims are to: (P1) Test the efficacy of PATHS in improving the degree to which AMSM are prepared for
intercourse (operationalized as: having access to condoms, demonstrating accurate condom skills, expressing
intentions to use condoms, receiving HIV testing, understanding what PrEP is, and expressing positive
attitudes toward PrEP); and (P2) Test the efficacy of PATHS in reducing condomless anal/vaginal intercourse.
Secondary (S) aims are to: (S1) Examine the degree to which intervention effects observed in P1 and P2
persist to 1-year post intervention; and (S2) Examine how parent behaviors mediate effects of PATHS on
AMSM outcomes. If proven efficacious, PATHS will be among the first interventions demonstrated to reduce
sexual risks and increase HIV testing for AMSM – the population of youth at highest risk for HIV infection in the
US. Moreover, as other adolescent-focused interventions emerge, PATHS’ unique focus on parents will offer a
complementary, additional means for reaching AMSM who are not touched by other intervention options.

Public health relevance
Project Narrative Gay and bisexual youth make up 80% of all new HIV infections among adolescents ages 14-19 in the United States, yet interventions to improve sexual health outcomes in these youth are extremely limited. Our team has developed an intervention to reduce HIV risk for gay and bisexual youth by working with their parents to improve the ways parents communicate with their sons about sexual health. We propose to deliver our intervention to parents of gay and bisexual teens ages 14-19 and to test whether it helps their sons by reducing sexual risks and increasing HIV testing.